Platelet alphaIIbbeta3 activation and its therapeutic targeting

Abstract
Platelet αIIbβ3 is required for normal hemostasis, but is also a validated drug target because of its essential
role in pathologic thrombosis. αIIbβ3 is normally kept in an inactive bent conformation on circulating platelets,
but rapidly switches to an active (ligand-binding) conformation in response to inside-out signaling. The ligand-
occupied receptor then transmits outside-in signals via the αβ transmembrane (TM) and cytoplasmic domains
that initiate platelet adhesion, a response inadvertently produced by current orthosteric inhibitory drugs, which
has limited their clinical efficacy. The structural basis of bidirectional integrin signaling remains to be clarified.
One model suggests that the ligand-binding site directly faces the plasma membrane in the bent conformation,
with integrin genuextension required for access to ligand. However, the integrin ectodomain/TM tilt has not
been defined experimentally. Further, regulated αβ TM domain association in integrins is driven by the
ectodomain, which may explain some of the differences found in the reported NMR structures of the isolated
αIIbβ3 TM domains. In preliminary studies, we produce a low-resolution cryo-EM structure of full-length αIIbβ3
in an unexpected orientation relative to the membrane, the result of its complex in cis with a tetraspanner,
providing the first experimental definition of an integrin ectodomain/TM tilt, and novel insights into the
structural basis of αIIbβ3 activation. We also develop a water soluble, stable and high affinity orthosteric
inhibitor of αIIbβ3 that is not a partial agonist, and use it in a structure-guided approach to generate like
compounds. We propose to expand on these preliminary data in three specific aims, utilizing multidisciplinary
approaches that include electron cryomicroscopy, tomography, protein crystallography, structure-based drug
design, new peptide synthesis technology and novel murine models of thrombosis.

Public health relevance
Project Narrative Integrin αIIbβ3 is critical for platelet aggregation, which underlies hemostasis but also pathological arterial thrombosis in heart attacks that claim the life of one American every minute. Drugs targeting platelet αIIbβ3 have improved outcomes in heart attack victims, but serious adverse outcomes linked to inadvertent receptor activation by the drug have limited their clinical efficacy, and underscored the need for better understanding of how activation of αIIbβ3 is regulated and for development of safer anti-αIIbβ3 therapeutics. In preliminary studies, we determined the first structure of αIIbβ3 in complex with an integral membrane protein, providing new insights into the regulation of αIIbβ3 activation, and a structure-guided approach for the design of novel and safer ligand-mimetic inhibitors of αIIbβ3, bases for the current proposal.